Tenth Small Genomes Conference-2002

DESCRIPTION (provided by applicant): This proposal is for a conference grant for the Tenth Small Genomes Conference (formerly the E. coli and Small Genomes Conference) to be held September 8-12, 2002, at the UCLA conference center at Lake Arrowhead, California. There is great excitement over the prospect of comparing the sequences and contents of as many as 200 microbial genomes over the 2-3 years. Considerable integration of different aspects of microbiology will undoubtedly take place, including new perspectives on evolution and the requirements for life. To achieve these goals, particularly of integration and synergy, scientists from diverse disciplines must interact. Thus, this conference will include active genome researchers, such as sequencing experts and informatics specialists working in database design, sequence analysis, or simulation; geneticists developing new methods to take advantage of genomic information, e.g. for functional analysis; and cell biologists and biochemists who have specialized in areas now ripe for genomics such as metabolism, chromosome structure, or gene regulation. One focus of this conference will also be on genomes of pathogens and biothreats, and a second focus on genome organization, This meeting has become established as a major annual microbial genomics conference during the last nine years and has assured status and quality.